MicroRNA 374 as an Epigenetic Regulator of Chronic Pain

Abstract
Chronic primary pain conditions (CPPCs) such as fibromyalgia and temporomandibular disorder (TMD)
constitute a significant healthcare problem that affects over 100 million, predominately female, Americans. The
origin of CPPCs is linked to genetic and environmental factors that enhance catecholamine tone. An estimated
2 in 3 patients with CPPCs have variants in the gene encoding catechol-O-methyltransferase (COMT; an enzyme
that metabolizes catecholamines) that result in low COMT activity and increased catecholamine levels. Pain in
these individuals is enhanced by stressful events (eg, motor vehicle collision) resulting in increased release of
catecholamines from sympathetic nerves. Our lab has shown that catecholamines drive pain via activation of
peripheral beta-adrenergic receptor 3 (Adrb3) and downstream mediators that regulate neuronal excitability and
immune responses. Catecholamine signaling has also been shown to alter the expression of microRNAs
(miRNAs), which are small non-coding RNAs that negatively regulate mRNA targets. However, the role of miRNA
dysregulation in CPPC pathophysiology remains understudied and unclear. Preliminary data from our case-
control study reveal that patients with TMD have decreased levels of miR-374. We replicated this finding in an
animal model of CPPCs where mice with low COMT activity exposed to stress exhibited pain and decreased
levels of miR-374. In the same mice, 5 miR-374 mRNA targets that were dysregulated in patients with TMD
(ATXN7, CRK, HIF1A, NUMB, and TGFBR2) were also dysregulated in adipose and spinal cord tissues, where
they are predicted to influence immune signaling and pain. HIF1A, NUMB, and TGFBR2 were upregulated in
adipose from female mice, while ATXN7 and TGFBR2 were downregulated in spinal cord from male mice. These
findings point to new RNA targets that may play an important role in pain related to heightened catecholamine
tone, yet mechanistic studies are needed to determine their causal role. Thus, the objective of this proposal
is to directly test the relationship between miR-374, its mRNA targets, pain, and inflammation. My central
hypothesis is that catecholamine activation of Adrb3 reduces levels of miR-374, leading to dysregulation of
mRNAs that promote inflammation and chronic pain in a sex hormone-dependent manner. I will use primary
adipocytes and neurons to measure 1) miR-374 binding to mRNA targets using a luciferase reporter system and
2) the effects of Adrb3 activation and sex hormones on miR-374 and mRNA target expression using qPCR. In
our CPPC mouse model, I will also measure 3) the effects of synthetic miR-374 overexpression and antagonism
on pain and cytokine production, and 4) miR-374 and mRNA target expression in distinct cell types using
combined RNAscope and immunohistochemical methods. These results will elucidate our understanding of
epigenetic mechanisms contributing to CPPCs and identify novel targets for improved treatment options for those
with these conditions. The proposed training plan will promote development of new in vitro and in vivo techniques
and foster career advancement in a highly supportive and collaborative environment at Duke University.

Public health relevance
Project Narrative Common chronic pain syndromes, such as fibromyalgia and temporomandibular disorder, constitute one of our nation’s most significant healthcare problems, yet are ineffectively treated because the underlying molecular mechanisms remain largely unknown. We hypothesize that these conditions are driven by catecholamine activation of beta-adrenergic receptor 3 and subsequent dysregulation in microRNA 374 which regulates the expression of genes important for pain and inflammation. Therefore, this proposal applies diverse methodologies in a clinically-relevant animal model in order to (1) define the relationship between beta-3 adrenergic receptor activation, microRNA 374, and complimentary mRNA expression with regards to cell type and sex, and (2) test the hypothesis that altered levels of miRNA 374 in mice directly contributes to pain.